Role of endoplasmic reticulum calcium in beta cell mitochondrial dysfunction, senescence, and onset of type 1 diabetes

PROJECT SUMMARY / ABSTRACT
Type 1 diabetes (T1D) is characterized by autoimmune-mediated destruction of the insulin producing β cells of
the pancreas causing severe hyperglycemia. Recent evidence suggests that the β cell itself plays a complex
role in T1D pathogenesis through activation of cellular senescence, which is associated with secretion of
chemokines and proinflammatory cytokines (SASP) that may act to amplify recruitment of immune cells,
making the β cells more vulnerable to immune attack. While senescence has been linked with mitochondrial
dysfunction in other cell types, the molecular pathways leading to β cell senescence and SASP are largely
unknown, leaving a critical need to determine underlying mechanisms to propel the development of novel T1D
prevention therapeutics. Calcium (Ca2+) plays a vital role in β cell function, regulating key steps involved in the
production and secretion of insulin. The fidelity of these tasks depends on the maintenance of Ca2+ stores,
organized at both the cellular and organelle level. The endoplasmic reticulum (ER) serves as a dominant
intracellular Ca2+ store, and ER Ca2+ is maintained through activity of the sarco-endoplasmic reticulum Ca2+
ATPase 2b (SERCA2) pump. We have shown previously that β cell SERCA2 expression is reduced in models
of T1D, leading to diminished insulin secretion, ER stress, and increased β cell death. My preliminary data has
extended these observations and linked loss of SERCA2 activity with decreased mitochondrial function and
increased expression of key senescence markers. Against this background, I hypothesize that loss of ER
Ca2+ via reduced SERCA2, accelerates β cell senescence and SASP via mitochondrial dysfunction
driving the development of T1D. I will test this hypothesis through two specific aims. In Aim 1, I will elucidate
the role of ER Ca2+ loss on islet β cell senescence, SASP, and mitochondrial function. In Aim 2, I will define
whether SERCA2 activation and/or senolytic treatments, which eliminate senescent cells, can attenuate T1D
onset, β cell mitochondrial dysfunction, senescence, and SASP. Completion of this project has the potential to
define a novel regulatory role for β cell ER Ca2+ and mitochondrial health during the development of T1D and
may inform new paradigms of T1D prevention. With this F31 Predoctoral Fellowship, I will be empowered to
complete my research strategy, while also focusing on my training plan, which includes 4 main objectives: 1)
Build a detailed and foundational understanding of techniques and concepts in diabetes research, 2) Build
strong technical skills in live cell imaging and single cell RNA sequencing analysis, 3) Develop and cultivate
mentoring skills, and 4) Enhance my critical thinking skills through written and oral scientific communication.
My training plan will be supported by the experienced faculty and collaborative research environment provided
by the Center for Diabetes and Metabolic Diseases and Herman B. Wells Center at the Indiana University
School of Medicine. In summary, this comprehensive research strategy and training plan will set me on a
trajectory to make a lasting impact in the field of T1D research.

Public health relevance
PROJECT NARRATIVE Type 1 Diabetes (T1D) is a costly condition that results from autoimmune-mediated destruction of the insulin- producing β cells of the pancreas, which necessitates relentless management of dangerously high and low blood glucose levels and is associated with a high rate of life-threatening complications and reduced life expectancy. T1D prevention promises the hope of significant economic, psychosocial, and public health benefits; however, this goal has yet to be realized from current clinical trials. The goal of this research is to understand how β cell stress responses contribute to T1D pathogenesis and will test the hypothesis that modulation of β cell mitochondrial health and prevention of β cell senescence through stabilization of endoplasmic reticulum calcium levels can attenuate the development of T1D.